PROSTATE CANCER PRACTICE PATTERNS AND HEALTH RELATED QUALITY OF LIFE

The primary goal of this National Cancer Institute Surveillance, Epidemiology and End Results (SEER) special study is to provide information about health-related quality of life (HRQL) following alternative treatments for clinically localized prostate cancer in a representative patient population treated in community practices. Data is currently being analyzed, with publications due to be completed by mid-1998.